Environmental Mutagenesis and Genomics Society (EMGS) Annual Meeting 2019-2023

The Environmental Mutagenesis and Genomics Society (EMGS) was founded in 1969 to provide a forum for the
establishment and support of scientists in the field of environmental mutagenesis. The mission of the Society is
(1) to foster scientific research and education on the causes and mechanistic bases of DNA damage and repair,
mutagenesis, heritable effects, epigenetic alterations in genome function, and their relevance to disease, and
(2) to promote the application and communication of this knowledge to genetic toxicology testing, risk
assessment, and regulatory policy-making to protect human health and the environment.
For the past 49 years, EMGS members have made many of the most important discoveries pertaining to the
mechanisms of the induction of mutations, the roles of DNA repair defects and resulting mutations in toxicology
and disease susceptibility, and the challenges of assessing risks from environmental exposures to mutagens.
Recognizing the importance of its diverse mix of professionals to exchange ideas and the latest experimental
findings, the EMGS held its first meeting in Washington, DC on March 22-25, 1970, and has continued this
tradition by providing a venue for these professionals to meet annually. Each year, the EMGS Annual Meeting
Program Committee strives to represent the full spectrum of strengths of the Society, encompassing most of the
areas of current research that converge on the issues of environmental exposure and how cells and organisms
respond to such challenges. In this proposal, we are requesting funds to defray part of the expenses for 2019–
2023 EMGS Annual Meetings.
The 2019 Program Committee has arranged for an outstanding and expansive scientific program that consists
of a workshop, symposia, and platform and poster sessions. To commemorate the 50th anniversary of our
Society, we have assembled speakers to talk briefly about the past, present, and future of some of the main
fields of interest represented by the EMGS membership. In addition to the scientific program, the Annual Meeting
will convene meetings of the nine Special Interest Groups (SIGs) that represent the diversity of the Society.

Public health relevance
Members of the Environmental Mutagenesis and Genomics Society (EMGS) have expertise in multiple disciplines covering all aspects of basic and applied research on mechanisms and consequences of responses to genotoxic agents. Integration of these disciplines remains the central focus of the Society, and the annual meetings are key to the dissemination of information and fostering of interactions between researchers and individuals who must make informed regulatory decisions with respect to environmental health hazards. The meetings provide a forum in which students, postdoctoral fellows, and early stage investigators can develop and enhance their careers by sharing information with established scientists through formal scientific sessions and informal interactions.